Innovative drug design technologies from computational mapping of energy, entropy, and free energy in proteins and protein-ligand systems

Project Summary/Abstract
This project aims to advance our understanding of structural mechanisms underlying protein-small molecule
binding – and ultimately of protein function – by developing novel computational methods for thermodynamic
mapping of proteins, ligands, and the surrounding aqueous solvent. Despite significant progress in structural
and computational research, the determinants of protein-ligand binding thermodynamics are not fully
understood, so it is difficult to reliably design ligands that will bind a targeted protein with high affinity. State-of-
the-art free energy perturbation (FEP) and related methods of computing protein-ligand binding free energies
can predict binding affinities with useful accuracy, but do not provide the insights needed to guide successive
rounds of ligands with improved affinity. Moreover, experimental studies have revealed poorly understood
couplings between binding sites and distant protein regions, highlighting opportunities to develop a deeper
understanding of how energy and entropy redistribute throughout proteins when they bind other molecules,
including small molecule drugs.
We aim to address these challenges by generalizing concepts of thermodynamic densities from liquids to
proteins and ligands, creating a new window into fundamental biomolecular processes. We will develop theory,
algorithms, and open-source software for generating structure-based maps of free energy, entropy, and energy
in proteins and surrounding water by analyzing molecular dynamics (MD) simulation trajectories. This work
builds upon recent advances unifying the theory of the entropy density of a liquid with the mutual information
expansion – hitherto only applicable to solutes – and defining the potential energy density for arbitrary
potentials. The software will be shared on GitHub for community evaluation, use, and development. We will
then apply these novel tools to map thermodynamic determinants of ligand affinity and guide computational
ligand optimization.
By assigning thermodynamic contributions to binding to specific system components, such as ligand functional
groups and protein sub-pockets, the new method will provide guidance toward the design of higher-affinity
ligands. We will also explore use of the new method to help identify ligandable cryptic sites in proteins, testing
two key hypotheses: 1) cryptic binding site formation is favored in high local free energy regions of the
apoprotein, and 2) ligands bind with highest affinity to pockets filled with thermodynamically unfavorable
solvent but with favorable intrinsic protein thermodynamics. These concepts also are expected to be useful in
broader aspects of molecular biophysics, such as understanding protein stability, energy storage and release
in molecular motors, allostery, and the free energy barriers controlling biomolecular kinetics.

Public health relevance
Project Narrative We aim to develop a novel theory that allows us to compute how energy is distributed in a biomolecular system, implement this theory in efficient software, and show how this new technology can be used to speed the discovery of new drugs. The basic idea is that a successful drug must bind tightly to a targeted protein molecule, and tight binding implies that binding is downhill in energy. The new technology will highlight parts of the drug-protein system where energy does not fall as much as it could upon binding, allowing the drug designer to modify the suggested drug to make it bind better, due to a stronger drop in energy, and will also highlight regions of the protein where new binding pockets may open up and thus enable targeting of hitherto undruggable proteins.